Commercialization of Enzyme Modified Carbon-Fiber Electrodes Paired with Voltammetry for Simultaneous Real-Time Monitoring of Electroactive and Non-Electroactive Species at Discrete Brain Locations

ABSTRACT
Commercially available, real-time molecular monitoring technologies are designed to selectively
measure only one molecule at a time at a given recording site. This is a problem because chemical
signals in the brain do not work in isolation; rather, neurotransmission involves many chemical
species simultaneously working to modulate neural circuits. Quantitative analysis of these
neurochemical signals is a critical first step when developing therapeutic strategies to treat
neurological/psychological disorders, but little is known about how specific neurochemicals
fluctuate relative to one another. The Sombers Lab has established the feasibility of using fast-
scan cyclic voltammetry (FSCV) and carbon-fiber microelectrodes for the real-time detection of
dopamine fluctuations while simultaneously detecting non-electroactive species, such as glucose
and lactate, at the same recording site. The microbiosensors have higher spatial and temporal
resolution than currently available technologies, minimal analyte consumption, and they can be
easily integrated into existing protocols. During Phase I, a 7-um probe was developed and
commercialized that can simultaneously measure dopamine and glucose in real time, at
single micron-scale recording sites in vivo. A software suite and FSCV tutorials were
developed. In Phase II, we will develop and commercialize 7-um dopamine/lactate,
dopamine/glutamate, and serotonin/glucose sensors. We will develop additional tutorials to
simplify access to this important technology, and we will continue to develop software and
electronics. Overall, this project is innovative, because it departs from the status quo by utilizing
the redox activity inherent to enzymatically generated H2O2 to identify targeted non-electroactive
species, even in the presence of electroactive molecules that are typically excluded as
interferents. It is significant, because it combines two state-of-the-art and well-characterized
technologies for neurochemical monitoring in a clever, straightforward, and unprecedented
manner. Ultimately, this project will provide the community with a sensor suite that can be used
to study the interplay of a range of critical analytes in complex physiological processes ranging
from basic endocrine function to motivation. It promises to have a transformative effect on
neuroscience by allowing researchers interested in diverse aspects of brain function to better
understand how these specific neurochemicals co-fluctuate in discrete brain locations.

Public health relevance
NARRATIVE This effort will enable researchers to simultaneously measure multiple chemical species at a precise point in the brain. In the United States, over 1000 disorders of the brain and nervous system result in more hospitalizations than any other disease group including heart disease and cancer. In 2020, an estimated 52.9 million Americans ages 18 and older — about one in five adults — suffered from a diagnosable mental disorder. Furthermore, an estimated 14.2 million (2020) American adults suffer from a serious mental illness in which the ability to function in daily life is significantly impaired (NIMH 2022). While symptoms of mental health disorders are well known, the underlying causes are often not. The multi-analyte sensors resulting from this effort will greatly aid the search for understanding and the development of cures.